Diversity Supplement to UC Davis CounterACT Center of Excellence: The role of the JAK/STAT signaling pathway in chronic neurological effects of acute organophosphate intoxication

Abstract
Convulsant chemical threat agents, such as the organophosphates (OPs) diisopropylfluorophosphate (DFP) and
soman, can trigger seizures that progress to life-threatening status epilepticus (SE). Survivors face significant,
long-term morbidity, including spontaneous recurrent seizures (SRS) and mild-to-severe memory loss. Current
medical countermeasures fail to sufficiently protect against these long-term neurological deficits. The work
described in this Diversity supplement will use a well-established rat model of acute DFP intoxication to test the
hypothesis that administering therapies that block the Janus Kinase/Signal Transducer and Activator of
Transcription (JAK/STAT) pathway as adjuncts to standard of care will mitigate the long-term, adverse
neurological consequences of acute OP intoxication. The scientific premise for this hypothesis includes
experimental evidence that: (1) JAK/STAT signaling has recently been implicated in the pathogenesis of
temporal lobe epilepsy; (2) this pathway is known to be involved in inflammation and immunity, and to be critical
for neuronal functions such as synaptic plasticity and synaptogenesis; and (3) it was previously reported that a
STAT3 inhibitor, WP1066, could greatly reduce the number of spontaneous recurrent seizures (SRS) in an
animal model of pilocarpine-induced SE. The research goals of this Diversity supplement are to: (1) Characterize
the spatiotemporal profile of JAK/STAT signaling in the brain of male and female rats following acute DFP
intoxication in order to determine therapeutic windows, and develop translatable biomarkers of inflammation that
predict SRS and/or cognitive dysfunction and (2) Evaluate the neuroprotective efficacy of WP1066 in male and
female rats acutely intoxicated with DFP. This research is complementary to and extends the research described
in the parent grant, which is focused on lipid mediators of neuroinflammation as therapeutic targets. The training
goals of this Diversity supplement include: (1) Develop the trainee’s knowledge and technical skill set to enable
them to successfully conduct research on medical countermeasures; (2) Guide the trainee’s research activity to
ensure the generation of data needed to support their preparation of a competitive F31 application and advance
to candidacy, was well as inform the feasibility of therapeutically targeting IL-1β signaling to mitigate the long-
term adverse neurological consequences of acute OP intoxication; (3) Enhance the trainee’s professional skills;
and (4) Actively work with the trainee to build their professional networks to enhance their likelihood of
transitioning to an independent career in academic research.

Public health relevance
Project Narrative: Acute treatment in the field with current medical countermeasures against chemical threat agents can save lives following acute intoxication with organophosphate (OP) nerve agents, but there are currently no effective therapies for those individuals who develop chronic spontaneous recurring seizures and/or cognitive dysfunction in the months to years following initial OP-induced status epilepticus. One goal of this supplement is to test the hypothesis that administering therapies that block the Janus Kinase/Signal Transducer and Activator of Transcription (JAK/STAT) pathway as adjuncts to standard of care will mitigate the long-term, adverse neurological consequences of acute OP intoxication. A second critical goal is to increase diversity of the scientific community with training on how to identify and develop more effective therapeutic strategies for reducing seizures and improving cognitive outcome in those patients who experience persistent drug-resistant disability following a chemical mass casualty event.